THE EFFECT OF DILTIAZEM ON EXERCISE HEART RATE IN CARDIAC TRANSPLANT PATIENTS

Diltiazem is used frequently in the heart transplant population. However, its negative effects on heart rate may further worsen pre-existing allograft chronotropic incompetence and patient exercise tolerance. This study will determine the effects of diltiazem on exercise capacity post transplant as measured by chronotropic response and peak oxygen consumption.